Profiling and characterization of genome-wide 3D promoter-silencer interactions

Project Summary/Abstract
The spatiotemporal regulation of gene transcription is tightly orchestrated by cis-regulatory elements, including
promoters, enhancers, insulators, and silencers. While transcriptional enhancers and promoter-enhancer
interactions have been extensively investigated across various cell types, our understanding of distal silencers
and how they regulate the target genes is still limited. Just like enhancers, they can regulate the target genes
from distance and function independently of their positions and orientations. It has been shown that silencers
also play a critical role in cell type-specific gene expression. Histone modifications have been frequently used to
annotate human genome and predict potential regulatory elements. Among them, H3K27me3, which is catalyzed
by the PRC2 complex, have been widely regarded as a potential marker to predict distal silencers. Recent large
NIH consortia such as ENCODE have produced ChIP-Seq for H3K27me3 in many cell lines, but there have been
limited effort to interrogate their roles in regulating gene expression and phenotypes through functional assays.
More importantly, there have been limited effort to determine the target genes for silencers and how they control
target genes from distance. To address these gaps, we propose the following aims: 1) To profile and characterize
promoter-silencer interactions by HiChIP for H3K27me3 in a variety of cell lines representing different tissue
origins. 2) To validate the function of distal silencers and promoter-silencer loops in gene regulation. We will
perform genome-wide STARR-Seq experiment to test the predicted silencers in five widely used ENCODE cell
lines. Then, we will also perform high-throughput CRISPRa screening (de-repressing) to investigate the silencer
functions in cell phenotype (proliferation). 3) To investigate the mechanism underlying the formation of promoter-
silencer loops. We will use AID system to knock out several potential factors involved in promoter-silencer
interactions, including CTCF, RAD21, and EZH2 in the same five cell lines. To complement the protein
degradation approach, we will also treat the cells with EZH2 inhibitor. We will perform RNA-Seq and HiChIP in
cells before and after the protein degradation or inhibitor treatment to investigate their roles in chromatin loops
and gene regulation.

Public health relevance
Project Narrative The goal of this project is to comprehensively identify distal silencer and promoter-silencer loops across a panel of cell lines of different origins. Through functional genomics experiments, we will also investigate how they contribute to gene regulation, cell phenotype and human diseases.